PARTNERS: Program to Advance Research and Transdisciplinary TraiNing in the CarE of PeRsons with Down Syndrome

SUMMARY Medical care advances have extended life expectancy in individuals with Down Syndrome [DS]1,
but substantial gaps in our understanding of the underpinnings, emergence, progression, and intersection of co-
occurring conditions in DS hamper surveillance and management recommendations. A major obstacle to
addressing these gaps is the limited availability of a trans-disciplinary, collaborative work force with expertise
and practical knowledge of working in the clinical research setting with individuals with ability differences
including persons with DS.
The goal of this trans-disciplinary training program (PROGRAM TO ADVANCE RESEARCH AND TRANSDISCIPLINARY
TRAINING IN THE CARE OF PERSONS WITH DOWN SYNDROME, PARTNERS) is to foster the development of a new
generation of investigators from diverse disciplines and backgrounds to pursue research in youth and adults with
DS. This program will pursue a “whole-person” curriculum that considers clinical, social, legal, ethical, and
research issues and perspectives related to persons with DS. These efforts are intended to supplement ongoing
training for health professional and graduate students, medical residents, post-doctoral fellows, and early-career
investigators.
To achieve this goal, training will include a week-long in-person short course at the Children's Hospital of
Philadelphia and will be supplemented by on-line materials and a year-long, monthly one-hour virtual meetings
and mentorship. The week-long course will consider 1) DS and its related co-occurring conditions, 2) ethical,
social, and legal issues surrounding research with the vulnerable population of persons with DS, 3) engagement
with patients with DS and caregivers of diverse backgrounds, 4) strategies for managing data (REDCap) and
pursuing scientific rigor, and 5) special considerations surrounding data analyses and interpretation; when
possible, hands-on experiences will be included. Additionally, 1) discussions with youth and adults with DS and
their caregivers and 2) small group sessions to provide feedback on emerging and ongoing DS-specific research
projects as well as career development will be included. Each presentation will highlight knowledge gaps in DS
research and existing datasets (including the NIH INCLUDE Data Coordinating Center) that can be leveraged to
address such gaps.
The
occurring
disabilities,
in
their
commitment
faculty include 1) clinicians with expertise in care fo individuals with DS and their co-
onditions, 2) clinica l researchers conducting research in youth and adults with DS or intellectual
3) experts in huma rights and disabilities, 4) established mentors and 5) physicians with expertise
medical education as well as clinica research staff with hand-on experienc engaging individuals with DS and
caregivers/support providers. Together these instructors have the varie expertise, resources, and
to training the next generation of investigators to advance research in persons with DS.
R25
PARTNERS r
c
n ,
l e
d

Public health relevance
NARRATIVE A major obstacle to addressing gaps in our understanding of Down Syndrome [DS] and its related co-occurring conditions is the limited availability of a trans-disciplinary, collaborative work force with expertise and practical knowledge of working in the clinical research setting with persons with DS. This week-long in- person short course for health professional and graduate students, medical residents, post-doctoral fellows, and early-career investigators intends to foster the development of a new generation of investigators from diverse disciplines and backgrounds to pursue research in youth and adults with DS. The program will pursue a “whole- person” curriculum that considers clinical, social, legal, ethical, and research issues and perspectives related to persons with DS.